International Society for Regenerative Biology Biennial Conference

PROJECT SUMMARY
This proposal requests partial funding for the first biennial conferences of the International Society for
Regenerative Biology (ISRB) to occur over a 5-year period, including its inaugural meeting in Vienna scheduled
for September 2-6, 2023. The ISRB is a foreign entity, registered as a charity in England and Wales. The ISRB
was established in 2021 with an overarching goal to formalize an inclusive and integrated community of scientists
that studies all aspects of tissue regeneration in invertebrate and vertebrate model organisms. These include a
dominant theme of basic discovery research, while also welcoming engineering and regenerative medicine
applications. There are currently 248 ISRB members, including 130 faculty, 56 postdoctoral fellows, and 62
graduate students. We anticipate our first in-person meeting will provide a major recruitment opportunity. More
than 50% of the current membership is located in the United States. The conference location of Vienna for 2023
is expected to increase European memberships and to provide opportunities for an international science
experience for many US trainees. The 2025 Conference will take place in North America at a site to be
determined in 2023, and the 2027 site will be determined later in the funding period. Functions of the ISRB are
to organize its own main conference and virtual events such as webinars, while supporting and enhancing other
workshops and small meetings. ISRB will convey the importance and impact of regeneration research to the
greater scientific and lay communities, highlight regenerative biologists and their discoveries, and promote
regenerative biology by giving awards for achievements and service, and by advocating for research and
community funding.
The ISRB biennial conference is intended to be the premier opportunity for researchers in the broad field of
tissue regeneration, across many species, tissues, and contexts of injury and disease, to meet and share data
and ideas. It will provide an interactive forum for students, postdocs and junior investigators to present their work
and interact with senior investigators, and to actively support diversity and inclusion in science. Enabling a
discourse regarding cross-species and cross-tissue comparisons will be key to enhancing understanding of the
commonalities and divergences in regenerative capacity and of the mechanisms regulating regeneration across
paradigms – toward the creation of an integrative framework. In this proposal, financial support is requested to
help defray conference fees for attendees, with a goal of ensuring diversity among attendees and to enable
attendance of those at early career stages.

Public health relevance
PROJECT NARRATIVE It is an aspirational goal of multiple research communities and funding bodies to provide core knowledge and new technologies to stimulate the body’s own ability to repair itself, but regenerative therapies have not been developed for most tissues or organ systems, including limbs, brain, heart, spinal cord, sensory systems, kidney, pancreas, and joints. The International Society for Regenerative Biology was founded to support and bring together researchers focused on discovering how to replace lost, damaged or diseased tissue with new, healthy tissue via therapies that do not require organ donation or transplantation. This proposal seeks support from the NIH to partially fund biennial international meetings of the International Society for Regenerative Biology to ensure timely dissemination of research findings and promote strong collaborative interactions throughout our research community.